The University Eduardo Mondlane/UCSD Health-Professional Education Partnership Initiative

We wish to build on a highly successful, decade-long multidisciplinary partnership between UC
San Diego (UCSD), the Universidade Eduardo Mondlane (UEM) and its affiliated academic
teaching hospital, Maputo Central Hospital (UEM) to help Mozambique achieve its long-term
goals of providing effective, comprehensive and affordable health care to all of its citizens. Our
main efforts are directed at relieving the chronic shortage of highly skilled health care workers
and health educators within its public Universities and health care system. We seek to improve
and expand professional training of health care workers and to create conditions under which the
best and brightest will choose to remain within Mozambique’s public Universities and health
delivery systems engaging in lifelong learning, providing outstanding patient care, engaging in
relevant research and training the health care work force that will transform Mozambican health
care through the middle of the 21st century.
Our general approach will be to leverage the substantial progress made under the UEM-UCSD
Medical Education Partnership (MEPI) at UEM and MCH to extend health education to the Central
and Northern regions of Mozambique by partnering with Mozambique’s three newest public
Faculties of Health Sciences in Nampula (UniLurio), Tete (UniZambeze) and Quelimane
(Universidade Pedagogica de Mozambique, UPM). We will, in addition, invest resources and
create linkages that will enhance the training of nurses, nurse educators and nurse researchers
at Mozambique’s primary institution for the higher education of nurses, the Instituto Superior de
Ciencias de Saude (ISCISA). We will experiment with the use of Emergency Medicine and
Trauma services to build bridges beyond physician training, to enhance outreach to rural
Mozambique and to take advantage of what is often a first point of contact with the health care
system to offer expanded HIV diagnostic, prevention and treatment services to populations not
currently in frequent contact with the health care system.

Public health relevance
We will continue to transform Mozambique’s health education system by substantially extending professional education in the health sciences beyond Mozambique’s capital, Maputo. To this end, we will partner with emerging Universities operating in the Central and Northern regions of Mozambique using multidisciplinary approaches geared to physicians, nurses and other members of the health care team.